TOXICOLOGY CONSULTING SERVICES FOR NINDS' HEAL PROGRAM

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

The Contractor shall provide toxicology consulting services to the NIH HEAL Program and to other NIH
neuroscience-focused drug discovery and development programs. Consulting services include:
• Providing input on project milestones, target product profiles, and testing funnels.
• Providing feedback on chemical structures and processes proposed by a chemistry service
contractor for each round of Structure-Activity Relationship (SAR).
• Evaluating SAR data as directed by the Contracting Officer’s Representative (COR).
• Toxicology Contractor(s) may be asked to evaluate the potential tractability (including
surrounding IP space) of a chemical structure for toxicology. Specific consulting responsibilities
will depend on the expertise of the Contractor and the needs of individual projects.
• In partnership with other consultants, contractors, and the NIH staff, advise, strategically plan and
manage toxicology programs to facilitate exploratory chemistry, hit-to-lead, lead optimization,
IND enabling, and clinical studies.
• Serving as the toxicology expert in identifying potential drug discovery and development
challenges, and suggesting strategies to address these challenges.
• Collaborating on design of investigative studies in support of NIH drug discovery and
development projects.
• As required by the Contracting Officer’s Representative (COR), accompanying NIH staff on
visits to Contract Research Organizations (CRO) under contract to the HEAL Program,
inspecting facilities, discussing appropriateness of CRO proposed methodology, and submitting
trip reports to HEAL program staff.
• Facilitating Lead Development Team discussions via telephone and email regarding assigned
toxicology efforts.